Proteogenomics of Cancer Training Program

ABSTRACT
This is a renewal application for our T32 Proteogenomics of Cancer Training Program (PCTP) at the
University of Michigan. The National Cancer Institute has made substantial investments in new technology
platforms for cancer proteomics, most recently through the Clinical Proteomic Tumor Analysis Consortium
(CPTAC). The proteome is critical to understanding functional genomics and systems biology of cancers
and to discovery and validation of biomarker candidates and molecular targets for therapy and prevention.
Sophisticated analysis of proteomes requires advanced informatics to deal with the complexity of
specimens, the extreme dynamic range of protein concentrations, post-translational modifications,
alternative splice isoforms, responses to all sorts of perturbations, and differences in databases and data
formats. Furthermore, integrative proteogenomics analysis of data generated using multiple omics
technologies (proteomics, genomics, transcriptomics, metabolomics, etc.) has emerged as a powerful
approach for reconstructing targetable pathways in cancer. The main goal of PCTP is to address the current
scarcity of scientists able to effectively generate and bioinformaticly analyze their own proteomics data, to
take advantage of CPTAC and other publicly available large-scale proteomics datasets, and to perform
multi-level proteogenomics data integration. PCTP is a truly multi-disciplinary Training Program that is also
very unique, with the U of M and nationally. Anchored in the university-wide Center for Computational
Medicine and Bioinformatics, it provides an opportunity to students from diverse backgrounds to become
well skilled in all PCTP focus areas - cancer biology, proteomics, bioinformatics, and proteogenomics.
PCTP is requesting 7 slots/year to supports pre-doctoral trainees for 1-2 years. We have a robust
community of cancer researchers, bioinformaticians, data scientists, statisticians, and chemists. Our faculty
and students are in the leadership of Human Proteome Organization initiatives, development and global
deployment of data repositories and data analysis systems, and creation of new algorithms for proteome
bioinformatics and multi-omics data integration. Our trainees come from larger Graduate Programs within
the U of M (including Bioinformatics, Pathology, Cancer Biology, Chemistry, and Biomedical Engineering)
and receive training in cancer biology, bioinformatics, and proteomics through courses, seminars, and
special workshops. PCTP strongly encourages dual mentorship of each trainee by a cancer researcher and
a computational scientist. We will further strengthen our Training Program with an addition of a special
Annual Workshop for our T32 trainees on Proteogenomics Data Analysis, taking advantage of our Faculty’s
engagement in the efforts of the CPTAC consortium. In summary, our ongoing NCI training program in
Proteogenomics of Cancer trains a new generation of scientists well prepared for an independent career in
interdisciplinary biomedical research, enhances faculty research, and supports NCI goals.

Public health relevance
NARRATIVE Very large, complex datasets are being generated by cancer researchers using new proteomics technologies that allow them to study thousands of proteins simultaneously. This avalanche of data requires scientists well-trained in the specialized and multidisciplinary field of proteomics. Insufficient numbers of scientists are being trained in this rapidly growing field and this T32 proposes to address this issue. !